Novel regulatory networks driving human ribosome biogenesis

Project Summary
Included in the Research Strategy per the guidelines PA 20-272

Public health relevance
Project Narrative This proposal is designed to answer important questions about the connections between making ribosomes and human disease. Ribosomes are the cellular factories that synthesize proteins in all human cells. As both cancer and genetic diseases of newborn babies are linked to abnormalities in the making of ribosomes, our work will be crucial for elucidating the underlying mechanisms of these diseases.